Tumor evolution in response to treatment

Tumor evolution is a dynamic process with continuous changes of tumor cells and the interactions with the tumor microenvironment. Based on single-cell transcriptomic profiles from liver cancer patients before and after treatment, we developed a novel CASCADE method to monitor tumor evolution. We demonstrated that a tumor's evolutionary trajectory may change over time in response to immunotherapy. We suggest mucosal-associated invariant T (MAIT) cells may contribute to patient response to immunotherapy.